Child Mental Health in HIV-impacted Low-Resource Settings in Developing Countries: Global Research Fellowship

Project Abstract/Summary
The proposed “Child Mental Health in HIV-impacted Low-resource settings in Developing countries: Global
Research Fellowship” (CHILD-GRF) training program will provide state-of-the-art methods training, mentoring,
and “hands-on” research experience to promising early career researchers committed to research careers
focused on addressing HIV prevention and the serious burden of child and adolescent mental health (CAMH)
in the context of HIV/AIDS. The overall expectation is to increase, strengthen, and sustain the capacity of
research institutions in Uganda, a sub-Saharan African (SSA) country heavily affected by HIV/ AIDS. CHILD-
GRF is guided by: Aim 1. Identify and train a cadre of 18 SSA scientists from Uganda (6 per year over 3
consecutive recruitment cycles) capable of serving as a Principal Investigators (PIs) on extramurally funded
studies focused on combination HIV prevention (CHP) addressing persistent poverty, community violence, co-
occurring CAMH problems, and HIV care and prevention in HIV-impacted communities. The program will
establish and provide: (a) multi-disciplinary training in substantive areas and methods for identification and
treatment of CAMH in HIV-impacted low-resource settings in developing countries, applying interventions that
have been culturally adapted to SSA along with training in methods focused on SSA context through a 3-year
summer intensive training at Washington University in St. Louis (WUSTL), led by multidisciplinary faculty, (b)
an intensive mentorship program and training infrastructure that fosters long-term research collaboration with
senior researchers and mentors from the global north and the global south; (c) hands-on learning opportunities
through activities between summers, including site visits to NIH funded research projects and centers focused
on HIV prevention and mental health interventions in communities heavily impacted by HIV/AIDS; (d) funding
for pilot studies; and (e) technical support and peer review for pilot studies, manuscript preparations, and grant
applications for larger studies. Aim 2. Bring together a network of committed mentors from the global north and
the global south to ensure quality training for promising new investigators from Uganda who would focus their
research on culturally-congruent interventions addressing HIV with an emphasis on co-existing CAMH and
CHP with potential implications for LMICs, including SSA. Aim 3: Delineate key factors that underlie successful
mentorship and training of new investigators from Uganda, with potential implications for new investigators
focused on CAMH and HIV-prevention interventions in LMICs, including SSA. CHILD-GRF has a structured, 6-
week intensive advanced summer training program. Each fellow will be paired with a mentor from WUSTL and
Uganda. A rigorous program evaluation will track individual fellow progress and program success. This
application is aligned with Fogarty's strategic priority of strengthening the scientific capacity of institutions in
LMICs to conduct HIV research relevant to the evolving HIV epidemic in their country.

Public health relevance
Project Narrative The proposed “Child Mental Health in HIV-impacted Low-resource settings in Developing countries: Global Research Fellowship” (CHILD-GRF) training program will support the development of a cadre of 18 well- trained, culturally-embedded in-country scientists from Uganda to conduct child and adolescent mental health (CAMH) research in the context of HIV/AIDS using rigorous and culturally-congruent research methods. This will ultimately provide a robust platform for the development and implementation of culturally-congruent evidence-based HIV prevention and CAMH interventions for youth and families living in communities heavily impacted by HIV/AIDS. By producing a sustainable network of individuals in key research institutions who are well trained in various aspects of CAMH, HIV/AIDS research, and dissemination & implementation research, this training program, in partnership with Makerere University in Uganda, will contribute to improving CAMH and HIV prevention efforts, both of which have implications for public health.